Visual Search and Detection in Natural Scenes

Project Summary/Abstract
The broad aim is to understand the mechanisms that underlie the ability of human and non-human primates to
locate and identify target objects under natural conditions, a ubiquitous and fundamental visual task.
Localization and identification of objects under natural conditions is difficult because there are so many
dimensions of uncertainty (variability) in natural tasks: highly-variable properties of the background scenes in
which the target object may be embedded, uncertainty about possible 2D (or 3D) location of the target object in
the scene, uncertainty about the 2D (or 3D) orientation of the target object, and uncertainty about the contrast
of the target object. These natural dimensions of uncertainty drove the design of the visual system (though
evolution and learning). Thus, the theoretical and experimental analysis of the effects of uncertainty is critical
for understanding the neural computations performed by the visual system, as well as the underlying neural
circuits. In preliminary studies, we made substantial progress in developing the theory of identification and
localization under natural conditions, in developing relevant computational and neurophysiological tools, in
making relevant behavioral measurements in humans, and in making relevant physiological measurements in
behaving monkeys. The first aim will be directed at rigorously testing a number of hypotheses about how
various dimensions of target and background uncertainty singly, and in combination, affect behavior and neural
computation. The second aim will be directed at measuring and modeling an important factor (partial masking)
that affects detection and identification performance in natural backgrounds, but has never been systematically
investigated in either simple or natural backgrounds. The third aim builds on the first two aims and will be
directed a developing and testing a new theory of overt and covert visual search that takes into account natural
scene statistics, variation in ganglion cell sampling and RF size with retinal location, and variation in intrinsic
position uncertainty with retinal location. The theory encompasses many specific models that each makes
detailed quantitative and qualitative predictions for arbitrary specific search stimuli. Covert and overt search
tasks in noise and natural backgrounds will be used to discriminate between models.

Public health relevance
Project Narrative Ultimate goals of vision science are to understand vision in the real world and to mitigate the effects of visual dysfunction on real-world performance. The proposed studies to develop a theory of overt and covert visual search performance in natural scenes will provide rigorous steps toward those ultimate goals and may lead to improved design of low-vision displays, environments, and training procedures.